Bayesian Data Augmentation for Recurrent Events in Electronic Medical Records of Patients with Cancer

PROJECT SUMMARY/ABSTRACT
Cancer and its treatment frequently result in sequelae that are not pro-actively reported but rather intermittently
assessed. For example, patients with cancer experience a higher rate of falls compared to the general
population, but falls are commonly reported only when elicited. Although electronic medical record (EMR)
databases capture these elicited reports, the assessments are intermittent and their intervals often overlap,
e.g., if patients are asked “have you fallen within the last three months” at two outpatient visits one month
apart. However, current methods for analyzing event counts within intervals when exact event times are
unknown (“interval count data”) require assessment intervals to be non-overlapping. This project addresses
this critical gap by developing Bayesian statistical methods and software for analyzing interval count data with
overlapping intervals, as arise from fall reports and other intermittently assessed EMR data. These methods
apply a Gibbs sampler in which one step uses Bayesian data augmentation to impute full event histories
(including event times) to which other steps may apply a broad toolkit of models for more fully observed
recurrent event data. In Aim 1 we will develop and apply Bayesian data augmentation for intermittently
assessed recurrent events following Poisson processes. Event histories will be imputed using specialized
rejection samplers optimized for high computational efficiency in our data setting. In Aim 2 we will develop and
apply Bayesian data augmentation for intermittently assessed recurrent events following renewal processes.
Event histories will be imputed using random walk samplers with specialized perturbation proposals. The
performance of both methods will be assessed via simulation study, and an R software package will be
developed and distributed to CRAN. In both aims we will evaluate incidence and risk factors for falls via EMR
data from an NCCN comprehensive cancer center using the developed statistical methods. Through our
proposed Bayesian data augmentation approach and software developed, this project will provide uniquely
capable and innovative tools to integrate clinical, demographic, and recurrent outcome data as commonly
recorded in EMR databases to assess incidence and risk, allowing for risk-stratified interventions. The tools for
recurrent events, though originally conceived of to address falls among patients with cancer and survivors, will
be broadly applicable to both other types of patient-reported sequelae such as occurrences of nausea and
pain, and other health-related fields that collect recurrent event data in EMR databases.

Public health relevance
PROJECT NARRATIVE In cancer and its treatment, many symptoms and side effects such as falls, pain, and nausea are only recorded in electronic medical records intermittently during encounters for other purposes. This project will develop innovative statistical tools for analyzing data with several challenges arising from this setting, such as only knowing whether at least one event occurred within the last three months at each encounter. We will use these methods to evaluate incidence and risk of falls among patients with breast cancer, but these methods will be broadly applicable to other types of recurrent event data in electronic medical record databases.